Targeting inflammation and oxidative stress to treat acute lung injury with CNP-miR146a

SUMMARY
Acute respiratory distress syndrome (ARDS) accounts for 10% of ICU admissions worldwide, with a mortality
as high as 46%. ARDS incidence has risen dramatically during the COVID-19 pandemic. Despite improvements
in critical care and early detection of lung injury, the management of ARDS remains largely supportive. Although
mechanical ventilation may provide the necessary life support, impaired pulmonary mechanics and subsequent
ventilator induced lung injury (VILI) can impose a second insult that worsens outcomes. A range of insults,
including trauma, sepsis, pulmonary infections, or toxin exposure, are associated with acute lung injury (ALI) and
the subsequent development of a systemic inflammatory response and progression to ARDS, leading to
alterations in lung compliance and lung fibrosis. A central pathogenic feature of ARDS is the persistent activation
of inflammation and oxidative stress. Following ALI, lung macrophages produce pro-inflammatory cytokines that
result in the recruitment of additional inflammatory cells and the generation of reactive oxygen species (ROS).
Persistent amplification of inflammation and oxidative stress leads to the progression to ARDS, promotion of
long-term fibrosis and morbidity.
Ceria Therapeutics is developing a novel therapeutic product, CTX-002, that synergistically targets both
inflammation and oxidative stress. CTX-002 (CNP-miR146a) is a cerium oxide nanoparticle (CNP), which
possess ROS scavenging properties, conjugated with an anti-inflammatory miR146a mimetic to target both ROS
and the inflammatory response. Supported by a Phase I application, we have demonstrated that a single
administration of CTX-002 can prevent bleomycin, MRSA, and lipopolysaccharide-induced inflammation and
lung injury, even when administered three or seven days after injury. In addition, treatment with CTX-002 resulted
in improved pulmonary mechanics and prevention of subsequent VILI. We also demonstrated that systemic
intravenous single and repeat-dose administration of up to 10-fold the intended clinical dose of CTX-002 showed
no signs of toxicity in rats. The objectives of this Phase II proposal are to 1) determine pulmonary distribution of
CTX-002 in pigs to demonstrate that intratracheal administration of the drug results in no systemic exposure of
CTX-002 but increased concentration in the lungs; 2) scale-up synthesis and complete analytical
characterization, formulation and stability of CTX-002; 3) perform GLP-compliant safety and toxicology studies
in rats and pigs. To complete this Phase II application, we will prepare and submit an IND for clearance to begin
first-in-human clinical trials of CTX-002 for ARDS.

Public health relevance
NARRATIVE Inflammation and oxidative stress are major factors in the pathogenesis of acute lung injury and progression to ARDS, for which no pharmacological treatments have been approved. CTX-002 is a special formulation form of CNP-miR146a for intra-tracheal administration, which prevents inflammation and lung injury, and is nontoxic upon systemic delivery in rodents. These efforts described in this proposal are intended to complete IND- enabling studies to file an IND for clearance to begin first-in-human clinical trials, based on recommendations from the FDA from our Pre-IND meeting.